PET:C11 LABELED NEURONAL NITRIC OXIDE SYNTHASE INHIBITOR THIOCITRULLINE

Recently, several reports have suggested that highly activated nN0S is partially responsible for the pathological effects of neurodegenerative diseases (Huang et al, Science 1994265:1883-1885: Zhang et al, Brain Res. 1994:654:85-95). S-methyl-L-thiocitrulline (MTICU), a potent and selective nN0S inhibitor (Ki=l.2 nM). has been reported to reduce the infarction size in a rat model of focal cerebral ischemia (Nagafuji et al, NeuroReport l995;6:1541-l545). MTICU is therefore a potential target for radiolabeling to probe nNOS in vivo. (C-11]MTICU was synthesized as published (Zhang et al, J. Label Compd. Radiopharm. 1995:37:240-242) with minor modification. Two mg of a-N-Boc-L-thiocitrulline t-butyl ester was alkylated with (C-11]methyl iodide at ll0 degrees C in acetone for 6 minutes. The solvent was evaporated under nitrogen before hydrolysis in 200 uL TFA at ll0 degrees C for 8 minutes. After HPLC purification, the final product was obtained within 50 minutes (Yield=9.1-12.5%. S.A.=22.2 GBq/mmol at E0S). HPLC analysis of blood samples. 30 minutes post-injection. indicated that (C-1]MTICU remained 64% intact in vivo, and 95% intact in vitro. The octanol/water partition coefficient (Log P=l.08+0.08 (n=6) and the biodistribution in female Sprague-Dawley rats were measured. Brain (0.11% 'ID/g) to blood (0.20% ID/g) ratio was 1:2 at 30 minutes post-injection. Total uptake in the brain was 0.19% ID/organ. Uptake of the tracer in the cerebellum, where nNOS distribution is most concentrated, was 20% higher than in both the cortex and the brain stem (p<0.05). (C-ll]MTICU uptake was also studied by co-administration of l mg/kg MTICU. The uptake in the cerebellum and the cortex were reduced by 22%, but the activity remained constant in the brain stem. (C-ll]MTICU was administered to a male baboon and brain images were obtained using a Siemens ECAT EXACT scanner. The (O-15]water and [O-15]carbon monoxide images were also obtained concurrently to detenmine the brain position and blood volume. Brain uptake of(C-ll]MTICU was stable ftom 5 minutes, remaining at 0.4% ID/organ, corrected for blood volume, up to one hour. Uniform distribution was observed in the brain of the normal animal. In conclusion, [C-11]MTICU is a tracer that has potential to be useful for the determination of nN05 levels in vivo.